Predicting Suicide Behavior Among High-Risk Veterans Using a Multimethod Assessment of Reactive Aggression

Although Veteran suicide prevention is the top VA clinical priority, a striking number of Veterans
attempt suicide: around 17 Veterans die by suicide each day. Decades of research have gone to
furthering VA’s understanding of suicide risk, yet some important risk factors remain understudied.
Reactive aggression, or aggressive behavior in response to provocation, represent a consistent, robust
risk factor for suicide behaviors among civilians, but is seldom studied as a suicide behavior risk factor
among Veterans. Further, the sparse existing research examining the association between aggression
and suicide in Veterans is limited by 1) conflation of reactive and proactive (unprovoked) aggression;
2) potentially misleading results due to inadequate power to predict low base-rate events, such as
suicide behavior; 3) an overreliance on self-report measures of aggression; and 4) a lack of attention
given to Veteran cultural factors relevant in understanding suicide risk.
The objective of this Career Development Award-1 (CDA-1) is to explore the association between
reactive aggression and suicide behaviors among a sample of Veterans at high-risk for suicide. This
objective will be accomplished with the following specific aims: 1) prospectively analyze the association
between self-reported current reactive aggression and suicidal behavior while controlling for past suicidal
behavior; 2) assess the acceptability and utility of a multimethod assessment of aggression; and 3) test the
unique contributions of specific military experiences (e.g., years of service, combat experience, date
since separation) to reactive aggression and suicide behaviors. To accomplish these aims, Dr. Krauss
will leverage Dr. Marianne Goodman’s (primary mentor) CSR&D-funded clinical trial of Project Life
Force (PLF; CX001705), a suicide safety planning intervention. PLF was recently selected as one of
the five ORD-funded research projects nationally to be featured for VA research Week 2022. Veterans
(N ~ 200) will complete self-report measures of reactive aggression and suicide behaviors and a
clinician-administered interview of suicidal ideation and behavior. Dr. Krauss will also administer a
clinician-administered interview and laboratory based task of aggression to a subset of Veterans in this
parent study as part of a multimethod assessment of aggression designed for this proposal.
This CDA-1 will provide support to advance Dr. Krauss’s goal of becoming an independent VA
research psychologist with expertise in suicide prevention among Veterans. To achieve this goal, Dr.
Krauss has crafted a rigorous yet attainable training plan with the following training goals: (1) gain new
knowledge and skills in suicide prevention research methodology; (2) learn how to administer and
interpret a multimethod assessment of aggression; (3) master advanced statistical techniques based
on counterfactual approaches to causal inference and modern missing data analyses; (4) identify
Veteran-specific experiences that contribute to suicide and aggression; and (5) improve competence
in VA grantsmanship and professional development. Given her research and clinical background in
aggression, this CDA-1 project is the natural extension of Dr. Krauss’s prior work. This CDA-1 training
plan includes mentorship from VA and academic experts in the field of suicide prevention (Drs.
Marianne Goodman [primary mentor], Joseph Geraci [mentor]), multimethod assessments of
aggression (Dr. Michael McCloskey [mentors]), advanced statistical techniques (Dr. Solomon Kurz
[mentor]), Veteran culture (Dr. Geraci), VA career development (Mark Ilgen [consultant]), and
Veteran aggression (Dr. Suzannah Creech [consultant]). Through the research and training aims of
this award, Dr. Krauss will be well positioned to develop a CDA-2 focused on developing a suicide
prevention program targeting aggression for Service Members/Veterans transitioning out of the military.

Public health relevance
This CDA-1 project will examine the extent to which reactive aggression acts as a suicide risk factor among Veterans and test the acceptability and utility of a multimethod assessment of reactive aggression. Reactive aggression is a robust suicide risk factor among civilians, but is understudied in Veterans. Four factors limit the minimal existing research among Veterans: 1) conflation of reactive and proactive aggression; 2) use of samples underpowered to predict suicide behavior; 3) overreliance on self-report measures of aggression; and 4) inattention to Veteran cultural factors. Dr. Krauss addresses each of these limitations in the current proposal while examining the extent to which reactive aggression predicts suicide behaviors in a parent study specifically powered to predict suicide behaviors. Findings from this proposal could identify reactive aggression as a potent, modifiable risk factor for Veteran suicide, which would greatly enhance VA’s current suicide prevention efforts.